Administrative Core

The goal of the Administrative Core of the COBRE Center for Central Nervous System Function is to support
the scientific, technical and mentoring goals of this COBRE Center by providing leadership and an
administrative structure to facilitate and coordinate the activities of the Pilot Project Program awardees, the
Principal Investigator, the Deputy Director, and the Director and staff of the Behavior and Neuroimaging Core.
These functions include: administrative support of the Principal Investigator and for all Pilot Project Leaders
and the Core Director, collection and maintenance of financial records for all Pilot Projects and Cores;
preparation of the annual Progress Report; coordinate activities of the Internal Advisory Committee, the
Steering Committee, and the External Advisory Committee in their roles of mentoring and evaluating the
research and personnel in each Project and Core; organize the COBRE's monthly research meetings and to
assist in data dissemination and sharing. Additional activities may include interactions with relevant
departments and programs in faculty searches, external seminar series, and internal journal clubs.